Effects of adversity and cultural protective factors on depression-related brain function in Mexican-origin individuals

PROJECT SUMMARY/ABSTRACT
This application is a Research Supplement to R01 MH123530. This application proposes a two-year
research and training plan for Angelica Carranza, a PhD student in Human Development at UC Davis. The aim
of the parent R01 is to establish the association between adversity in adolescence and depression symptoms
and allostatic load in young adulthood for those of Mexican origin, identify neural mechanisms mediating these
associations, and discover protective factors that can mitigate these processes of risk. The proposed Research
Supplement will expand on the proposed research but remain within the scope of the original parent grant by
addressing two research aims. First, to use growth curve modeling to examine how trajectories of economic
hardship and perceived discrimination in early/mid adolescence prospectively predict neural connectivity
associated with reward processing and social exclusion in late adolescence. Second, to examine how two
potential cultural protective factors for Mexican-origin individuals, ethnic identity and familism, moderate
associations between adversity and neural connectivity. The proposed Research Supplement will also support
Ms. Angelica Carranza in accomplishing the following four training goals: 1) developing expertise in longitudinal
statistics, particularly growth curve modeling, 2) advanced training in fMRI analysis, 3) training in culturally-
sensitive research methodology for Latino populations and development of expertise in culturally-specific
protective factors for mental health in Latino populations, and 4) career development including writing and
publishing manuscripts and grant writing. The proposed research and training plan will ensure that Ms. Carranza
has the skills needed to pursue her future career goals of obtaining a postdoctoral fellowship and, later, a position
as a professor at a research university.

Public health relevance
PROJECT NARRATIVE This Research Supplement proposes a two-year research and training plan for a graduate student in Human Development to gain expertise in advanced statistics, advanced neuroimaging analysis, culturally-sensitive approaches to studying mental health in Latino populations, and career development. This project is relevant to NIMH’s mission because it characterizes developmental processes that give rise to mental illness and identifies protective factors to serve as novel intervention targets, and this application addresses NIMH’s commitment to improving training and advancement of researchers from diverse backgrounds who will advance research in mental illness.